Evaluating maternal and newborn health inequities at the intersection of race, ethnicity, and disability in the U.S

PROJECT SUMMARY (ABSTRACT)
People with disabilities experience pregnancy at the same rate as people without disabilities but have
disproportionately higher rates of adverse outcomes including pregnancy, labor and delivery complications,
severe maternal morbidity, maternal death, preterm birth, stillbirth, low birth weight, and infant mortality rates.
Although there is limited information about the extent of racial and ethnic disparities in maternal and newborn
health outcomes among those who are disabled, current evidence suggests that these inequities are even
more pronounced among racial and ethnic minorities compared to their White counterparts. Developing
effective interventions to eliminate inequities at the intersection of race, ethnicity, and disability requires a
comprehensive understanding of the relationships between these multiple levels of inequity and associated
birth outcomes. This project aims to fill this research gap using a social determinants of maternal health lens to
analyze linked maternal-infant Medicaid claims, natality, and mortality data files. Three research aims are
proposed. Aim 1 focuses on the magnitude of racial and ethnic disparities in low birthweight, small for
gestational age, preterm birth, and neonatal mortality at the intersection with disability; Aim 2 evaluates the
extent to which disparities in these outcomes at the intersection of race, ethnicity, and disability are moderated
by area-level socioeconomic inequities; and Aim 3 evaluates the association between race, ethnicity, and
disability in nationally established quality measures for maternal-infant health. The proposed aims are
supported by the PI’s career training goals, which include developing expertise in 1) using Medicaid claims
data to produce measures of adverse birth outcomes by race, ethnicity, and disability, 2) analyzing area-level
social determinants and quality of care measures associated with maternal and newborn health disparities, and
3) understanding disability measurement, public insurance coverage, risk factors for poor health, and
community priorities needed to design effective interventions to reduce maternal and infant health inequities in
this population. The proposed project supports the PI’s long-term career goal to become an independent
investigator and advocate for maternal and newborn health equity in the U.S., with a particular emphasis on
identifying and addressing the disparities resulting from social inequities using rigorous methodologies. Career
development will include a series of formal courses, training workshops, and directed readings that will be
completed with faculty at Dartmouth and other institutions over the first two years with additional topics covered
as needed in the subsequent years. Attendance at conferences and related workshops will also be added to
stay informed of current developments in the field. The award will be followed with a Research Project Grant
(R01) to develop and test an intervention to improve outcomes among those most burdened by adverse
outcomes at the intersection of race, ethnicity, and disability in the U.S.

Public health relevance
PROJECT NARRATIVE In this K01 Career Development Award, I will lead an in-depth study of risk factors associated with poor maternal and newborn health outcomes in a Medicaid population with disabilities in Texas to better understand the disparities faced by this population with respect to race and ethnicity, area-level socioeconomic conditions, and quality of healthcare. This study will include birthing people and their newborns across an urban-rural continuum and diverse socioeconomic environments with a comprehensive assessment of low birthweight, small for gestational age, preterm birth, neonatal mortality, and four quality of care indicators. The findings will add to our knowledge of adverse birth outcomes among racial and ethnic minorities with disabilities in the U.S. and inform targeted interventions and policies aimed at reducing the health inequities experienced by this population.